Cancer Prevention and Control (CAPAC) Research Training Program

Project Summary. Research being performed in Puerto Rico provides an opportunity to advance knowledge
of cancer risk, and cancer prevention and control among Hispanic and non-Hispanic populations in the United
States (US). The Cancer Prevention and Control (CAPAC) Research Training Program at the Division of
Cancer Control and Population Sciences of the University of Puerto Rico Comprehensive Cancer Center aims
to increase the pool of master’s degree graduates and other health professionals that pursue a doctoral degree
and/or a career in cancer prevention and control research with a focus on Hispanic health and health
disparities. The program will recruit participants from all racial/ethnic groups and cultural backgrounds to
participate in a hands-on research experience in a Hispanic population and cultural environment. Participants
will be matched to a mentor based on their research interest in basic, clinical, and population-based research.
The CAPAC aims to: 1) Recruit 20 master level and health professional students (and recent graduates from
these programs) per year to participate in hands-on research experience in cancer prevention and control; 2)
Provide participants with a mentored hands-on research experience in cancer prevention and control research
with a focus on Hispanic health and health disparities; 3) Provide program participants with the skills to pursue
a doctoral degree and/or a career in cancer prevention and control research, and 4) Conduct process and
outcome evaluation of short-, intermediate-, and long-term goals. The CAPAC Program will increase
participants’ understanding of the spectrum of cancer prevention and control research, strengthen their skills in
cancer research, and increase their cultural sensitivity skills. Potential areas of cancer prevention and control
research will include topics within the cancer control continuum: prevention, early detection, screening and
survivorship, and topics that are relevant within the mission of the National Cancer Institute (cause, diagnosis,
prevention, treatment of cancer, rehabilitation from cancer, and the continuing care of cancer patients and the
families of cancer patients). The duration of the program is 10 weeks. Upon request and evaluation of the
request, the program will support a maximum of 10 participants to extend their research experience to a
maximum of 15 weeks. The hands-on cancer research experience will be overseen by a cancer
researcher/mentor, to whom each student will be assigned. Areas of expertise of the proposed mentors include
basic, clinical, population-based and translational research. Educational activities will include seminars and
workshops that will strengthen the participant’s skills to pursue a doctoral degree and careers in cancer
prevention and control research. Outcomes of interest to determine program success will include: (1)
participant and mentor satisfaction with the program, (2) mentor’s satisfaction with the participants, (3)
participants that become co-authors in scientific presentations and/or manuscripts, and (4) participants that
continue doctoral studies and/or careers in cancer prevention and control research.

Public health relevance
Relevance: This program will provide hands-on, mentored research experiences to master level and health professional students (and recent graduates from these programs) from all racial/ethnic backgrounds on cancer prevention and control research with a focus on Hispanic populations. Research being performed in Puerto Rico provides an opportunity to advance knowledge of cancer risk among Hispanic and non-Hispanic populations in the US. Given the high burden of cancer and the associated cancer health disparities among Puerto Rican this training will not only increase the knowledge of participants on cancer among Hispanics, but also their cultural sensitivity towards Hispanic populations.